Protection of Salivary Gland in PSMA-targeted radioligand therapy

The goal of this project is to see if salivary gland uptake of PSMA injected systemically can be blocked selectively blocked by using local blocking methods at the salivary gland level. The desired end point would be blocking salivary gland uptake of PSMA without affected the tumor update. This is a collaboration with Dr. Blake Warner of the Dental Institute and involves the use of rodents as the pre-clinical model. If the pre-clinical approach is successful, the approach will be translated to humans in a future clinical trial.